ASMB 2023: Tissue, Matrix, and Pathobiology

We request partial support for the 11th Biennial American Society for Matrix Biology (ASMB) conference entitled
“Tissue, Matrix, and Pathobiology”. This in-person meeting will take place October 22-25, 2023 in Salt Lake City,
Utah. This is a new multidisciplinary and collaborative joint meeting among three major societies: ASMB, the
American Society for Investigative Pathology, and The Histochemical Society. It will feature cutting edge basic,
clinical, and translational research related to a variety of topics that reflect normal biology of cells/tissues, and
the molecular and cellular alterations that drive disease processes. This meeting will have a common keynote
speaker and 3 common Plenary Sessions of interest for all members of the three societies. Importantly, the
meeting will have an ASMB tailored program focused on promoting the field of matrix biology in order to
disseminate knowledge about the extracellular matrix (ECM) and to translate this knowledge to improve human
health and aging and to better treat human disease. The Aims of this R13 application are:
Aim 1: To disseminate and integrate new knowledge about ECM and its receptors in health, disease, aging, and
regeneration. The ASMB 2023 program reflects the diverse interests of the matrix biology scientific community.
It expands and evolves areas of interest for matrix biology, such as the tumor/stroma microenvironment; aging-
related diseases involving ECM changes; the role of sex and diet in ECM changes and disease; cardiovascular
and musculoskeletal injury and regeneration; bone and cartilage development, disease, and regeneration; tools
to study ECM signaling; and technologies for therapeutic intervention and for imaging ECM in health and disease.
Aim 2: To contribute to training the next generation of scientists, and to foster the careers of junior investigators
in the area of ECM. ASMB 2023 has invited junior faculty to speak in both Plenary and Concurrent Sessions.
Each Concurrent Session will have a co-chair chosen from junior faculty and/or senior postdocs and talks
selected from submitted abstracts, giving trainees and junior faculty opportunities to present their work. ASMB
2023 will also offer postdocs the opportunity to organize and chair special interest sessions. Career mentoring
breakfasts and interactive poster sessions will also support career development. ASMB’s Junior Investigator
Award, Founders’ Award, and Iozzo Trainee Awards will highlight junior scientists. Travel Awards will be provided
to competitive trainees. Aim 3: To enhance diversity and inclusion by promoting the career of women and under-
represented minorities (URM). ASMB 2023 will showcase the work of 5 women (of 9 speakers) in 3 Plenary
Sessions; 4 women and 1 URM (of 9 speakers) in 3 Guest Symposia; 8 women and 2 URM (of 16 speakers) in
16 Concurrent Sessions. Of a total of 39 invited speakers, 17 are women (43%). A mentoring breakfast devoted
to career development issues particular to women will also be held. In the selection of speakers, we have focused
on including those from diverse backgrounds. In addition, ASMB has reserved travel awards for URM trainees.
Overall, this conference will be, as it has always been, the seminal conference in the field of ECM research.

Public health relevance
The 11th Biennial Conference of the American Society for Matrix Biology (ASMB) will take place October 22-25, 2023 in Salt Lake City, Utah. The purpose of the ASMB biennial meeting is to bring together researchers who study the role of extracellular matrix and cell/matrix interactions in health, aging, and disease to share knowledge, network, and establish new collaborations to improve human health. Other major goals are to highlight junior investigators, provide mentoring for trainees, promote diversity and to ensure the participation and success of historically under-represented groups in the in the field of matrix biology.